Core 3: Biostatistics and Bioinformatics Core

CORE 3: PROJECT SUMMARY
The goals of the Biostatistics and Bioinformatics Core are to address the study design and analysis needs of the
Yale SPORE in Skin Cancer (YSPORE) projects, the Developmental Research Program (DRP), and the Career
Development Program (CDP), and to address the analytical and data management needs of the Biospecimen
Core. Drs. Krauthammer and Ma will continue to serve as Co-Directors of this Core, and will be assisted by
statisticians and bioinformatitions with unique expertise and extensive experience. The Specific Aims of the
Biostatistics and Bioinformatics Core are as follows. Aim 1: Provide biostatistical and bioinformatics support to
all YSPORE projects and investigators. The Core will provide timely and comprehensive support to address
questions arising from the YSPORE projects. Our service will cover the whole spectrum of the studies, including
study design, data management and analysis, result interpretation, and preparation of manuscripts, abstracts,
posters, and applications. The Core will have regular research meetings with YSPORE investigators and
maintain an open door policy for all analytic needs. Aim 2: Provide effective data management for YSPORE
projects. The Core will offer data management services to all projects and investigators and ensure that all NIH
data-sharing regulations are properly followed. This includes deposit of properly curated data to repositories
such as GEO, SRA, dbGaP, and others. Aim 3: Develop innovative biostatistical and bioinformatic methods
tailored to melanoma research. Data with more complex characteristics will be generated by YSPORE, TCGA,
and other studies. As an independent intellectual contribution, the Core will develop new analysis methods which
will facilitate more effective utilization of data and foster melanoma analytic research. Aim 4: Promote program-
specific research and training opportunities involving biostatistics and bioinformatics trainees and faculty. The
Core will promote opportunities within existing Yale programs and centers, including the Yale Graduate Program
for Computational Biology and Bioinformatics (CBB), Yale Center for Medical Informatics (YCMI), Yale Center
for Analytic Sciences (YCAS), and others. During the past and current funding period, the Core has made
significant contributions to research and training, which is partly reflected in our strong publication record and
successes in training postdoc associates and graduate students. We will continue to do so in the proposed
funding period. The Core will borrow strength while not overlap with that of other SPORE(s) and Yale
Comprehensive Cancer Center (YCC). The Core will also be a key partner in the YSPORE with representation
on the Senior Leadership Team and participation in all key meetings.

Public health relevance
CORE 3: PROJECT NARRATIVE With a stellar team of bioinformaticians and biostatisticians, the Core will provide the whole spectrum of analytic support to all YSPORE projects and investigators. The Core will ensure that all studies are properly designed and executed and that data are properly managed, analyzed, reported, and published.